Improved Diagnosis and Treatment of Cushing's Disease

We discovered that although corticotropinomas are benign tumors, they undergo metabolic reprogramming much like malignant cancers. We found that metabolic reprogramming is mediated via isozyme switching of Hexokinase-1 (HK-1) to HK-2, lactate dehydrogenase A (LDH-A) to LDH-B and by nuclear targeting of 6-phosphofructo-2-kinase/fructose-2,6-bisphosphatase-3 (PFKFB3). We also posit that nuclear targeting of PFKFB3 provides a causal mechanism for downregulation of cell cycle inhibitor p27 in human corticotropinomas. We found that human corticotropinomas overexpress glucose transporter 1 (GLUT1) that allows increased uptake of glucose. We then demonstrated that GLUT1 expression can be transcriptionally modulated by stimulation with secretagogues such as corticotropin releasing hormone (CRH). We have translated these findings to improve FDG-PET detection (a marker of glucose uptake) of corticotropinomas (NIH Protocol 12-N-0007).5 We found that CRH stimulation led to increased mean FDG uptake in adenomas. Frequently, these tumors are invisible on MRI imaging. With CRH stimulation, blinded neuroradiologists were able to detect 40% of MRI invisible pituitary adenomas on PET imaging. We showed that corticotropinomas rely on glucose and the glycolytic pathway for survival. Selective inhibition of HK-2 with 3-bromo-pyruvate led to significantly decreased glycolytic activity and cell survival specifically in human corticotropinomas while sparing the normal gland. We then found that by using drugs that specifically target GLUT1 expression in tumors (such as a histone deacetylase inhibitor SAHA), we were able to decrease survival and hormone secretion in human corticotropinomas ex-vivo. Normally, ACTH secretion is modulated by promoter activation of the POMC gene by a heterodimer of retinoic receptor (RXR) and liver X receptor (LXR). We found SAHA transcriptionally downregulated LXR selectively in murine tumor cells in-vitro but not in normal corticotrophs. Based on these findings, we are now initiating a clinical trial of oral SAHA in patients with CD to test its efficacy in normalizing hormone levels pre-operatively. Using the large clinical dataset of CD patients that is uniquely available at NIH, we developed a critical insight that the post-operative state represents an endogenous stress test. This insight now allows clinicians to predict hormonal remission after surgery for CD from just one post-operative serum hormone data point. We were also able to use this dataset to derive predictive rules that could help clinicians predict the durability of such hormonal remission. Successful pre-operative imaging of millimeter sized pituitary adenomas can lead to improved surgical outcomes in CD. We are advancing imaging to help detect these adenomas. We developed a novel MRI coil that is designed to be used during surgery for CD6 and we are now starting a first-in-human trial of this coil. We also found that delayed post contrast MRI imaging was the most useful strategy to detect small, otherwise MRI invisible adenomas. We now want to further characterize metabolic reprogramming in corticotropinomas with the aim of developing viable anti-tumor strategies. Corticotropinomas share common features that separate them from other kinds of pituitary tumors. We want to identify the proximate causes for corticotropinoma tumorigenesis and the drivers/facilitators of oncogenic signaling. For this purpose, we will explore the regulation of a known tumorigenic mutant protein USP8 as well as analyze epigenetic events that could propagate oncogenic signaling.